InheRET: A SaaS solution to identifying patients at increased risk for hereditary disease

Project Summary This project is to complete the development, integration with the electronic medical record and human testing of the InheRET Inherited Risk Evaluation Tool. InheRET’s aim is to quickly and easily identify individuals at increased risk for hereditary diseases, thereby facilitating their to access downstream risk-appropriate care, reducing morbidity and mortality. InheRET’s unique features reduces clinical ascertainment barriers by gathering a patient provided family history, produces a report based on patient and family history that streamlines workflows and enhances patient outcomes and cost effectiveness within health systems. The aims for this project are to complete in silico (computer generated) testing of the algorithms driving the InheRET data analytics for the case of cancer risk, followed by pilot testing in a variety of clinical settings to determine if further refinements are needed to the product, prior to commercialization. As part of this STTR project, we will integrate the InheRET program with an EPIC electronic health record system to seamlessly communicate InheRET reports within the patient medical records, to be accessible to both patient and practitioner. Success will be determined if we achieve 100% concordance with the in silico testing (i.e. concluding that all algorithms function correctly), 98% concordance with clinical determinations in the clinical pilot testing, and 100% concordance in the integration testing (all patient reports are appropriately routed to the proper medical records). Our primary objective is to produce an accurate, easy-to-use and understandable report to ensure individuals who may unknowingly harbor inherited genetic mutations are identified, thereby enabling them to access genetic counselors and testing along with appropriate downstream care. By doing so, patients can reduce their risk of disease, receive tailored treatment if they incur disease, and reduce overall mortality. Moreover, InheRET will cut costs by assisting in focusing resources on those whose risk warrants enhanced measures. Conversely, by reducing incidence of hereditary cancers or the advanced presentation of cancers or other hereditary chronic illnesses, a multitude of costs associated with complex treatments can likewise be reduced, while increasing quality and length of life.

Public health relevance
Project Narrative This project is to complete the development, integration and testing of the InheRET Inherited Risk Evaluation Tool. InheRET’s aim is to quickly and easily identify individuals at increased risk for hereditary diseases enabling them to access downstream care, reducing morbidity and mortality. InheRET’s unique features reduces clinical ascertainment barriers, streamlines workflows and enhances profitability within health systems.